Experience Design, Communications and Marketing for the All of Us Research Program

Our Vision and Strategy for the Next Five Years: Optimizing and Expanding the All of Us Experience Over the next five years, we look forward to building on the foundation we have created through our long-standing partnership with the NIH and consortium partners. Specifically, our goals are to further develop and enrich the All of Us experience for new and existing participants and to build out an intuitive, efficient experience for diverse sets of researchers from across the nation. In year one, we will advance design research and experience design initiatives that focus on holistic experience strategies for [I] participants and [II] researchers. This research will move program priorities forward and ensure that we deliver the right experience to the right people at the right time.